Cellular and biophysical interactions to build oocyte-follicle complexes

Project Summary
How do animals make eggs? Sexual reproduction is necessary for the continuity of most animal species and
requires the production of egg cell precursors called oocytes. As individuals are delaying having children until
later in life and may be subject to genetic and disease-related stressors, a substantial fraction of the population
will be impacted by fertility challenges. The goal of this proposal is therefore to determine fundamentally how
oocytes develop, which may inform new reproductive therapies. Oocytes develop in the ovary in complexes
called follicles, where they are enveloped in somatic granulosa cells that support their development. This
proposal aims to determine how oocytes interact with these granulosa cells to build follicles, and how oocytes
and granulosa cells communicate with each other across the thick extracellular layers separating them.
Studying folliculogenesis in mammals is challenging because oogenesis occurs only once in a hard-to-access
fetal window. In contrast to mammals, the sea star Patiria miniata produces new oocytes in existing ovaries
and regenerates entire ovaries throughout its adult lifespan. P. miniata is an echinoderm, a member of the
sibling group to chordates, and thus is more closely related to mammals than many other invertebrate models.
P. miniata follicle cells also share substantial gene expression and structural features with mammalian
granulosa cells. These features, in addition to our ability to culture ovary explants long-term in the lab, make
sea star oogenesis an accessible, genetically tractable, and biomedically relevant model.
Aim 1 of this proposal defines the structure, function, and dynamics of microtubule-based projections (OMPs)
that emanate from the oocyte toward the follicle cell, under the hypothesis that they serve as signaling
organelles. This is done by microinjecting oocytes with fluorescent microtubule probes and GFP-fusion
constructs for candidate structural and signaling proteins to determine their localization. This aim also defines
the life history of OMPs, how their dynamics are affected by the presence of follicle cells, and their functional
importance for oocyte developmental competency. Aim 2 investigates the cellular dynamics and forces
required for follicle formation, using live and fixed imaging of follicle-building. It further asks what cytoskeletal
components are involved in building a follicle and how this is affected by the physical properties of the ovary
extracellular matrix. This is done using live imaging, a coupled in vivo – in vitro approach, staining of
cytoskeletal and ECM components, and inhibitor and reconstitution experiments. Together, this work will
uncover the physical basis of follicle formation and provide a framework for future studies of how follicle
formation changes during aging. This proposal also takes advantage of the unique expertise and biological and
microscopy resources available at the Marine Biological Laboratory in Woods Hole.

Public health relevance
Project Narrative Oocytes, which are the precursors to egg cells, develop in the ovary in structures called follicles where they are wrapped in somatic granulosa cells. In this project, I will study how granulosa cells move to form follicles around newly-developing oocytes, how this process is affected by the physical environment of the ovary, and how oocytes and granulosa cells communicate with each other. This will inform future studies of reproductive aging, conditions such as polycystic ovarian syndrome, and the development of assisted reproductive therapies such as IVF.